Computational, Neural, and Behavioral Studies of Competition-Dependent Learning

The overarching goal of this renewal application is to understand how stored memories change as a function
of experience, and how these changes support our ability to discriminate similar stimuli. The inability to make
such distinctions can lead to mundane errors and memory interference, but also devastating cognitive, semantic,
communication, and developmental deficits. We focus on the challenging scenario when the differences between
stimuli are subtle and the stimuli appear at different times, requiring memory. The specific goal of this proposal
is to understand the interacting roles of the hippocampus and cortex in this scenario. Recent studies have found
that the key to behavioral discrimination is differentiation of hippocampal representations — a phenomenon
whereby the representations of similar stimuli are pushed apart beyond the orthogonality of pattern separation,
to the point of anti-correlation. Crucially, existing computational models of the hippocampus do not exhibit differ-
entiation and thus cannot provide a satisfactory account of memory-based discrimination learning. The major
significance of this proposal is to remedy this critical gap, by formulating and testing a new neurocomputational
theory that explains the causes of hippocampal differentiation and its consequences for discrimination behavior.
Aim 1 breaks new theoretical ground by incorporating our theory of how unsupervised learning gives rise to
differentiation (developed in the prior funding period) into a biologically grounded neural network model of hip-
pocampus and its interactions with cortex, which will be used to explain existing results and to generate novel
neural and behavioral predictions about discrimination learning. Aim 2 tests these predictions with fMRI. A key
prediction is that the hippocampus has a time-limited role in discrimination learning, supporting activation of
unique features of similar stimuli in visual cortex after (but not before) differentiation, then relinquishing this role
after consolidation. This prediction and others are tested using new fMRI decoding methods based on deep
learning to quantify how strongly visual cortex represents unique features of paired stimuli, and how this relates
to hippocampal activity. Aim 3 combines innovative experimental approaches with greater causal leverage to
further test model predictions: real-time closed-loop fMRI to manipulate cortical inputs to the hippocampus; in-
tracranial EEG (iEEG) to measure the temporal precedence of hippocampal signals driving representation of
unique features in visual cortex; and responsive neurostimulation (RNS) to transiently disrupt hippocampal pro-
cessing in patients with chronic implants. In summary: This proposal tightly couples theoretical neural network
modeling with experimental tests of model predictions using advanced correlational (fine-grained fMRI decoding,
consolidation-related EEG signals) and causal (real-time fMRI, iEEG, RNS) human neuroscience methods. This
work provides pivotal basic science insights into how the hippocampus supports learning. These insights may
facilitate the development of evidence-based learning paradigms that improve discrimination behavior, with po-
tential application to new treatments for psychiatric and neurological disorders.

Public health relevance
Project Narrative Our ability to distinguish similar perceptual inputs is crucial for everyday functioning (e.g., what information to share with which person, which objects are safe to eat); failing to make such distinctions can lead to mundane errors and memory interference, but also to devastating cognitive, semantic, communication, and developmental deficits. This combined computational and experimental project proposes and tests a new theory of how two key brain structures — the hippocampus and visual cortex — collaborate to support learning of distinctions through a process of differentiation. The resulting knowledge will advance our fundamental understanding of memory in the human brain and guide the creation of evidence-based training curricula for learning to distinguish people, places, and things that otherwise risk being confused, with potential applications to new interventions for psychi- atric and neurological disorders.